Developing Adhesome Technology as a Physical Marker of Highly Metastatic Cells

Project Summary Diagnostic markers have improved our ability to identify tumors at earlier stages, but secondary metastases are still exceedingly common and aggressive. Metastases result from primary tumors shedding a small subpopulation of stem-like cells that can migrate through adjacent stroma and disseminate throughout the body unlike those cells remaining in the primary tumor. Progress towards identifying molecular prognostic markers of these stem-like cells that could assess metastatic risk has been limited; very recently however, evidence has suggested that a tumor's physical state may act as an alternative prognostic marker . We have observed that one such physical marker—adhesion strength—varies in metastatic epithelial cell lines from mammary, prostate, and lung tumors due to differences in focal adhesion assembly in stromal-like conditions, e.g. low Mg+2 and Ca+2. Thus strongly adherent sub-populations are slower and less processive than their unselected counterparts. Our hypothesis is that the converse population, i.e. weakly adherent tumor cells in the stroma, represents the most metastatic sub-population, which can be purified based on their adhesion strength and counted to determine metastatic risk. To isolate this converse population of weakly adherent cells, we have developed an “adhesome” flow chamber assay that will subject cells to low shear (<10 dynes/cm2) in stromal-like environments and rapidly (<10 min) sort 107 cells. Using this technology for proof-of-concept in Aim 1, we will validate its sorting efficiency and fidelity and observe the potential of weakly adherent cells to detach, migrate, and invade engineered microenvironments that resemble adjacent tumor stroma. In Aim 2, we will test the adhesome flow chamber's ability to predict breast cancer metastatic risk in vivo by injecting selected cells into mammary fat pads. We will then assess the propensity of weakly or strongly adherent cells to form or not form metastases, respectively. Cells from primary tumor stroma will be directly assessed to identify cells with a weakly adhesive signature and correlate that with secondary metastasis formation as would occur in the clinic. By validating across tumor types, this Innovative Molecular and Cellular Analysis Technologies R21 proposal will establish an adhesome flow chamber technology and validate our hypothesis that weakly adherent tumor cells are capable of migrating and forming secondary metastases, i.e. establish metastatic risk. Thus this technology should provide clinicians with addition prognostic assessment of a tumor's metastatic risk.

Public health relevance
Project Narrative Not all cells within a tumor are capable of metastasizing, but highly metastatic cells are weakly adherent in stromal conditions to facilitate their migration and formation of secondary tumors. We will establish “adhesome selection” devices that will purify these highly metastatic cells from heterogeneous cell lines and the stroma of xenograft tumors. These technical assessments will develop proof-of-concept that weak adhesion in stromal conditions can be used as a prognostic indicator of the metastatic potential of tumor-derived cells.